Bladder cancer PD-L1 control of homologous recombination: Basic mechanisms applied to novel treatments

This
revised
MPI proposal assembles experts in bladder cancer, tumor biology, DNA damage response (DDR)
and pre-clinical models with a long-standing history of productive collaborations to study effects of intracellular
bladder cancer PD-L1 signals on BRCA1-mediated DDR, and how such signals alter sensitivity to PARP
inhibitors and immune checkpoint blockade immunotherapy in orthotopic/metastatic mouse and human models.
We test transplantable mouse bladder cancer lines MB49 and MBT-2, and the human bladder cancer lines RT4,
UM-UC3 and UM-UC14, representing basal and luminal histologies plus new PDX, xenograft and organoid
models and our novel GEMM all per reviewer request
. Intracellular PD-L1 signals are interrogated using control
versus genetically manipulated tumors and other approaches
including new non-biochemical approaches per
reviewer request
. We will use these clinically relevant models together to test our overarching hypothesis that
bladder cancer PD-L1 signals promote the homologous recombination DDR pathway that suppresses
PARP inhibitor and immune checkpoint blockade immunotherapy efficacy.
Aim 1: Define mechanisms for PD-L1-mediated control of HR. We will use well-validated genetic,
biochemical and pharmacologic approaches plus definitive cell reporter assays for homologous recombination,
RNA-seq, proteomics, RPPA, immunoblots,
CRISPR library screens, organoids
and digital imaging with image
analysis software to understand how PD-L1 regulates BRCA1 functionality and to test mechanisms, including
for tumor immunogenicity. We identified FDA-approved pharmacologic agents that we repurposed to deplete
tumor PD-L1 and inhibit HR, for which we define mechanisms.
Aim 2: Define treatment consequences of PD-L1 controlled homologous recombination/BRCA1 effects.
Control versus genetically PD-L1 depleted cells with genetic perturbations of BRCA1 and related molecules will
be tested for in vivo effects by challenging engineered cells into mice and treating with single agents or
combinations, based on findings from Aim 1 to assess treatment efficacy and specific mechanisms. We use
transplantable, syngeneic mouse models, and human xenograft and humanized mouse models
in which we have extensive experience. Notably, we will assess tumor microenvironmental and immune
contributions to treatments using genetically immune altered mice, adoptive cell transfers and immune
blocking/neutralizing molecules. In vivo data are mechanistically refined in in vitro assays in which we are expert.
PDX, organoids

Public health relevance
Bladder cancer is the costliest cancer to treat due to repeated recurrences and low cure rates. We show that PD-L1 expressed on bladder cancer modulates the DNA damage repair response to afford important basic mechanistic insights into DNA damage repair and to help show how such data can develop effective bladder cancer treatments including with novel pharmacologicPD-L1 depletion drugs. These findings are related to improved treatment strategies in many other important cancers including melanoma and those of breast and ovary.